Medical Imaging Technology Development Core

ABSTRACT – Medical Imaging Technology Development Core
The objective of the Medical Imaging Technology Development Core (MITDC) is to build an infrastructure to
support research of the junior research project leaders (RPLs) and overarching goal of this COBRE. The Core
will be built based on the OU Advanced Medical Imaging Center (OU-AMIC), which has been supported by both
the Gallogly College of Engineering University of Oklahoma (OU) Norman campus and the Stephenson Cancer
Center of OUHSC campus since 2012. OU-AIMC includes 5 research laboratories and an established network
between the engineering and clinical expertise to facilitate the interdisciplinary research. OU-AIMC provides a
solid foundation for this MITDC to provide important resource for RPLs and pilot project awardees of the COBRE.
The MITDC Core has 3 Specific Aims. Aim 1: We will implement an interdisciplinary management plan to build
an optimal infrastructure to support translational medical imaging related cancer research. The Core will be co-
directed by an experienced engineer and a physician researcher. An advisory board of senior engineering and
physician researchers will be established to guide the development and operation of the Core. Existing imaging
equipment and other tools will be integrated to serve COBRE projects, along with equipment and services
available by industry and clinical collaboration. Monthly brainstorming meetings, on demand tours, round table
discussions, and biannual open house workshops will facilitate interaction between members of the Core and
researchers on both OU Norman and OUHSC campuses. These activities will allow the Core to better understand
researcher needs and provide opportunities for researchers to learn new imaging technologies that can benefit
their research. Aim 2: We will design and develop a series of investigative imaging tools and testbeds to provide
researchers fast and cost-effective methods to test their innovative research concepts. Using testbeds of new
imaging modalities, the researchers will be able to acquire preliminary data to validate their hypotheses without
the expensive and time-consuming development of a fully equipped laboratory. Based on the research areas of
the initially selected RPL projects and other junior researchers in the COBRE pool, the testbeds will include, but
are not limited to, phase-contrast X-ray imaging, X-ray fluorescence tomography, digital pathology scanners,
and special optical imaging devices. Aim 3: We will build an integrated computer server/network and provide
new computer-aided quantitative image feature analysis schemes and software to support the RPLs and other
researchers to conduct large data and deep transfer learning-based Radiomics studies. This will improve the
efficiency and consistency of developing and validating quantitative image markers and/or machine learning
prediction models developed by different projects. In summary, MITDC will provide a unique research service
and supporting capability to enhance the overarching goal of this COBRE. It will not merely be a collection of
imaging equipment in a distinct space, it will also allow us to fully network our current research expertise to better
support the translational cancer research using medical imaging technology to benefit patients in the future.